EFFECT OF FEMORAL ARTERY CATHETERS ON LOWER LIMB

This study is intended to examine the effects of prolonged (up to 7 days) femoral arterial catherization on subcutaneous growth of the leg. Study subject consists of children admitted to the Pediatric Intensive Care Unit. During the past 8 years who have only had one leg catherized. Measurements will be done by 2 observers using a tape measure. Controls will be the non-catherized leg.